Beta Adrenergic Antagonist For The Healing of Chronic Diabetic Foot Ulcers

Intro: This study will investigate the safety and efficacy of using timolol, a non-selective beta
adrenergic antagonist (BAA), topically to treat diabetic foot ulcers. We hypothesize that topical
timolol is more effective in achieving wound closure than using the standard of care (SOC)
treatment for diabetic foot ulcers, and is a safe therapeutic alternative.
Research Design/Methods: The study is a Phase 2 randomized, double blinded, controlled
and parallel-group clinical trial with 2 treatment arms, receiving either the SOC plus topical
Timoptic-XE® or a control group receiving SOC plus a non biologically active gel (hydrogel, as
placebo medicine).
The study population will be selected from the VA Northern California Health Care System,
Veterans who present with diabetic foot ulcers. We will require 24 subjects enrolled in each
treatment arm, for a total of 48 sample size to provide a power of 80% to detect a 43 %
difference, with 63% healing in the timolol group and 20% with the standard of care, at a
significance level 0.05 and an overall attrition will be 35%.
We will perform simple allocation of the subjects using an electronic randomization for
treatment assignment. Following recruitment, patients that have met the eligibility criteria and
signed an informed consent, will then undergo two weeks of baseline screening to screen out
rapid healers. Next, the patient will be randomly assigned treatment, with unique identifiers
assigned, with subject and investigator blinded as to treatment. Subjects will topically apply
daily either the treatment medication or the placebo on the foot ulcer for 12 weeks, or until
healed, whichever comes first.
Measurements of wound size and other data will be collected at baseline, followed by weekly
visits for 12 weeks, and then a follow-up period. The maximum study duration for any subject is
31 weeks with 3 phases (two weeks in the Screening Phase, up to 12 weeks in the Active Phase
including a confirmatory visit, followed by a second confirmatory visit a week later, and one
month and three-month in the Follow-Up Phase).
Analysis: The primary end point of wound closure (skin re-epithelialization without drainage
or dressing requirements) at 12 weeks will be analyzed using the two-sided Fisher's exact test.
Secondary outcomes such as the rate of ulcer healing by the 12th week of care, time to achieve
complete ulcer closure, recidivism, occurrence of adverse events will be analyzed with p- value
adjustments. A two-way ANOVA with a post hoc test will be used to relate timolol serum levels
to wound healing. The analysis of the wound characteristics, the subjects' characteristics, and
the safety parameters will be performed using logistic regression. Subjects will complete the
Veterans Rand (VR-36) Health Survey to evaluate quality of life, the Lower Extremity
Functional Scale, which will be analyzed along with the Charlson co-morbidity index, using
ANCOVA.

Public health relevance
One in four Veterans is affected by diabetes and will develop a diabetic foot ulcer. Diabetic ulcers are very challenging to manage and are the most common cause of leg amputation. Many advanced treatments are expensive and difficult to use in the clinic or at home. Those newer therapies have shown little success in healing diabetic foot wounds. Our laboratory and animal work has suggested that a safe medication, currently used as an eye drop for treatment of glaucoma, can heal these ulcers. We are proposing to test this drop (timolol) directly on the surface of the foot ulcer to see if it can improve healing faster than the current standard of care. To do this, we propose a “randomized controlled trial” with two groups of patients with diabetic foot ulcers: one will receive standard of care with timolol while the other will receive standard of care with a gel (hydrogel, as placebo medicine).